Yale Training Program in Health Services Research

Project Summary
This proposal requests a renewal and expansion of our existing T32 research training grant, from 4 to 6 pre-
doctoral trainees and from 2 to 4 post-doctoral trainees annually. The Yale program is based in the Department
of Health Policy and Management in the School of Public Health, engaging core faculty from two other
departments within YSPH and ten other departments outside YSPH. The program is now in its fifteenth year,
having supported 36 trainees (19 pre-docs and 17 post-docs). The metrics of success are clear: trainees
complete the program in a timely manner; trainees have published XX unique articles based on their program
engagement; 95% of those who have completed the program are currently in research-intensive or research-
related positions, many at top-tier universities. Our rationale for the proposed expansion is based on the
program’s distinctive approach to its mission: to train young scholars who are skilled at working in cross-
disciplinary teams, who are committed to tackling problems of real-world importance, and who are engaged in
the process not simply of creating policy-relevant findings, but also translating those findings into practice. The
program design reflects these objectives. It incorporates multiple mentors for each trainee to provide them with
cross-disciplinary exposure; it integrates trainees into a highly collaborative network of research preceptors,
embodying our expectations that trainees will be willing and able to pursue team science throughout their
careers. The program fosters a commitment to translating research into practice by requiring predoctoral
trainees to pursue applied field experience (the TRIPP) to help them better understand the practical and
institutional realities of the fields affected by their research. Post-doctoral trainees learn methods for
community-based participatory research to complement their other methodological skills. Both pre- and post-
doctoral trainees can connect with two centers advancing implementation science, one fostering innovative
methods, the other exemplary stakeholder engagement. Over its history, the program has evolved to more
effectively foster in young scholars a commitment to research that has lasting impact. Over the next five years,
we anticipate continued evolution, most notably incorporating (a) an enriched exposure to cutting-edge
methods to allow trainees not only to assess and but also to enhance healthcare equity, (b) analytic skills
needed to tackle emerging health threats, such as policy modeling to inform responses to COVID and other
emergent health threats, and (c) an expanded integration of clinicians into post-doctoral training in ways that
enrich their abilities and those of non-clinician trainees.

Public health relevance
Project Narrative This training program is designed to develop early career scholars who identify timely research problems, conceptualize creative responses, apply cutting-edge research techniques, and effectively guide the translation of findings into policy and practice. Our trainees are prepared to tackle the complex ways in which contemporary health and health care problems transcend disciplinary boundaries. Their published work, both during and after completing the program, has had a demonstrable impact on health care, healthcare equity, as well as the policies and practices that affect both.